Mindfulness-based Interventions for Healthy Aging: Elucidating Neural Mechanisms of Focused Attention and Open Monitoring

PROJECT SUMMARY
The proposed research training plan uses a multimodal EEG/fMRI approach to elucidate the psychotherapeutic
mechanisms of mindfulness-based interventions (MBIs) for older adults. Although MBIs have demonstrated
promise for addressing the mental health needs of a rapidly aging population, very little is known about how
exactly MBIs work in the elderly. The long-term objective of this proposal is therefore to fill this dearth of
knowledge in service of advancing the clinical and basic science of healthy aging. Toward this end, the focus of
the project is to examine how the development of focused attention (FA) and open monitoring (OM)—MBI-
specific skills trained through meditative practice—influence neurobehavioral measures of emotion regulation
and cognitive control as a function of older adult participation in Mindfulness-Based Stress Reduction (MBSR).
Prospective participants and data for this project will come from the longitudinal Mindfulness-Based Stress
Reduction, Healthy Education and Exercise (MEDEX; R01 AG049369) study. Rather than evaluating outcome
measures pre-post MBSR, the proposed research will innovatively leverage the MEDEX parent sample by
comparing FA/OM practice in older adult participants whom completed MBSR relative to controls. The study will
be one of the first to rigorously investigate how neural activity during FA and OM meditation relates to “off-the-
cushion” target measures of emotion regulation and cognitive control. Moreover, training in fMRI and network
neuroscience will be used to elucidate the effects of MBSR on intrinsic brain connectivity and test whether MBSR-
related changes in network connectivity can predict FA/OM meditation quality and degree of psychotherapeutic
benefit.
The training component of the project is grounded on three goals: (1) develop proficiency in cutting-edge fMRI
techniques and data science programming; (2) acquire the requisite skills to conduct mindfulness-based
intervention research for older adults; (3) pursue interdisciplinary collaborations to advance research at the
intersection of aging and contemplative science. The training will be completed over three years via an intensive
program of direct mentoring, coursework, and workshops in relevant analytic techniques. Furthermore, there will
be hands-on immersion in conducting research with older adults, and research collaboration with eminent
scholars in the fields of aging and development, cognitive neuroscience, clinical psychology, and contemplative
science. Completion of the proposed research and training could mitigate age-related cognitive decline and
emotional disorders by tailoring existing MBIs to optimize benefit for older adults, leading to a healthier aging
population.

Public health relevance
PROJECT NARRATIVE As the world population enters an unprecedented era of aging, emotional distress and cognitive decline in old age will be an increasing source of human and economic burden. Developing targeted psychological interventions for older adults, with firm understanding of their effectiveness and underlying therapeutic mechanisms is therefore paramount for facilitating healthy aging and reducing the burden of age-related mental health problems. Consonant with this priority, the current research proposal will combine cutting-edge methods from psychophysiology and cognitive neuroscience to rigorously evaluate how mindfulness-based interventions can enhance emotion regulation and cognitive control in older adults.